In vivio single-cell analysis of dynamic cell behaviors

Imaging plays an increasingly important role in studying development and complex tissue formation across
molecular, cellular and tissue levels. Fluorescence 3D time-lapse imaging allows every cell in a tissue or entire
organism to be imaged, tracked and measured over hours and days to analyze lineage differentiation and
dynamic cell behaviors. Other modalities, e.g., electron and expansion microscopy reveal fine structural
phenomena, while emerging genomics technologies, e.g., spatial transcriptomics, seek to merge with
microscopy to further provide systematic molecular information. Effective tools of image analysis are crucial to
extract, integrate and interpret the information. We propose to leverage the power of deep learning to develop
image analysis tools for systematic in vivo single-cell analysis, and to leverage such analysis to study collective
cell behaviors in tissue morphogenesis, with three Aims. First, we will develop deep learning methods for
accurate cell tracking, which is the essential first step to trace cell lineages and measure dynamic cell
behaviors. We aim to produce a tool that can deliver substantial cell lineages with hundreds to thousands of
cells imaged over hours to days in a wide range of model organisms and organoid cultures. Second, we will
automate landmark-based image registration, which is crucial for cross-modality data integration. We propose
a generalizable approach that uses statistical templates and Neural Networks to address the unique challenge
in developmental images, namely heterochrony of developmental processes that creates combinatorial
configurations of landmarks and complex systematic co-variance. Third, we study a novel Planar Cell Polarity
(PCP) scheme in C. elegans, which we discovered through cell tracking and deep learning of cell movement
patterns. By dissecting the compound polarity scheme and context specific regulators, we aim to understand
how the conserved core PCP pathway can coordinate with different polarity pathways in order to orchestrate
diverse motile behaviors in diverse developmental processes. By integrating technology development and
hypothesis driven research, our proposal will further our understanding of embryogenesis and complex tissue
formation.

Public health relevance
This project takes a multidisciplinary approach involving live microscopy, genetics and computational sciences to address novel mechanisms that mediate cell movement and achieve tissue morphogenesis. The biological insights and the tools developed in this project will ultimately help us understand complex tissue formation in humans and birth defects.